MICHIGAN DEPARTMENT OF AGRICULTURE & RURAL DEVELOPMENT FFM-MFRPS MAINTENANCE & FOOD PROTECTION TASK FORCE MAINTENANCE

Project Summary – Abstract RFA-FD-23-027
The Flexible Funding Model - Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Programs (FFM) three (3) year grant opportunity
focuses on the maintenance of long-term sustainable efforts at the state and local
levels to improve capabilities in human food regulatory programs.
The Michigan Department of Agriculture and Rural Development (MDARD) is the lead
state agency for human food safety with authority to oversee all segments of the farm-
to-fork continuum. The over-arching goal and vision in Michigan is to maintain a high-
quality regulatory food program and to improve the effective working relationships
with the FDA-ORA OHAFO HAFE6, the Michigan Department of Health and Human
Services, Michigan's 45 Local Health Departments, academia, and industry
stakeholders.
The grant opportunity would allow Michigan to improve its capabilities to help
advance a national integrated food safety system by continuing to maintain full
conformance and implementation with Manufactured Food Regulatory Program
Standards and to foster collaboration in food safety with stakeholders utilizing the
Food Protection Task Force.

Public health relevance
Project Narrative RFA-FD-23-027 The Flexible Funding Model (FFM) funding support will allow Michigan the opportunity to continue efforts to maintain a sustained approach to protect human health through food safety efforts. We have achieved and maintained full conformance and implementation with the most current version of the Manufactured Food Regulatory Program Standards (MFRPS). MFRPS will continue to be utilized to advance Michigan's efforts to be more consistent and uniform with federal and other state food regulatory programs, to establish a basis for measuring and improving performance, and to direct activities towards reducing food borne illness to further the nationally integrated food safety system.